A Randomized Controlled Trial of Prophylaxis with Direct-acting Antivirals for Kidney Transplantation from Hepatitis C virus-infected donor to Uninfected Recipients (PREVENT-HCV)

Due to epidemics of opioid overdose and hepatitis C virus (HCV), the availability of kidneys from HCV-viremic
(HCV+) donors is increasing. There are limited numbers of HCV+ transplant candidates, and as a result 500-
1000 HCV+ donor kidneys are discarded each year. A new practice of HCV+ donor to HCV-naïve recipient
(HCV D+/R-) kidney transplantation (KT) with direct-acting antivirals (DAAs) has had early success. However,
there remains equipoise about whether to give DAAs as prophylaxis or as treatment post-transplant (“transmit-
and-treat”). With transmit-and-treat, HCV is cured with 8-12 weeks of DAAs, but complications such as
fibrosing cholestatic hepatitis, rejection, CMV, and BK virus are reported. Prophylaxis seems to prevent these
complications but data is limited. A direct comparison of prophylaxis and transmit-and-treat has not been done.
Determining the best strategy would allow for expansion of HCV D+/R- KT and minimize clinical complications.
We propose PREVENT HCV, a multicenter randomized controlled trial comparing DAA prophylaxis with
transmit-and-treat in HCV D+/R- KT. We will perform 120 HCV D+/R- KTs over 2 years at 6 transplant centers.
Aim 1 will compare the safety and efficacy of transmit-and-treat (SOF/VEL for 12 weeks starting day 14 post-
KT) vs prophylaxis (SOF/VEL for 2 weeks started several hours pre-KT). We will also measure clinical
complications of HCV D+/R- KT such as liver injury, rejection, and infection with these two strategies.
In this trial, the exact timing, size, and genetic composition of the transmitted viral inoculum will be known,
providing an unprecedented opportunity to study the earliest events in primary HCV infection. Leveraging this,
Aim 2 will characterize the earliest viral dynamics and phylogenetics of early HCV in the liver and blood, as
well as the transmitted virome, identifying emerging viruses, including SARsCoV2, some of which have been
implicated in rejection. Aim 3 will characterize the innate immune response to primary HCV, measuring
cytokines and the transcriptome of innate immune cells. These studies can contribute new knowledge about
HCV related to vaccine efforts and deeper understanding of the virome, generalizable beyond transplantation.
Our multidisciplinary team includes experts in Transplant Surgery, Infectious Diseases, Nephrology,
Epidemiology, Biostatistics, Pathology, Virology, and Immunology. Our team has experience successfully
enrolling and conducting multicenter transplantation trials (U01AI134591, U01AI138897) and will leverage
existing infrastructure for operations, data management, analysis, and safety monitoring.
In summary, PREVENT HCV will quantify clinical risks of HCV D+/R- KT and determine the optimal DAA
approach. This could facilitate thousands of additional KTs, contributing to one of the mandates of the White
House Executive Order on American Kidney Health. Finally, this trial includes unique mechanistic studies that
can generate fundamental insights into the biology of primary HCV relevant to vaccine efforts, and knowledge
about the transmitted virome and its significance in immunocompromised hosts.

Public health relevance
Due to epidemics of opioid overdose and hepatitis C virus (HCV), organs from HCV+ donors are increasingly available, however thousands are currently discarded that could benefit individuals in need of a transplant. A new practice of transplanting HCV+ donor organs into individuals without HCV, in combination with HCV medications, has shown early success. This proposal includes a trial of HCV+ donor kidney transplantation in order to determine the best timing and duration of HCV medications, and scientific studies that will improve our understanding of HCV infection and immune responses, as well as novel viruses.